Immunology Core

This Core component will take advantage of our established vaccine evaluation pipeline, which includes our
innovative high throughput approaches facilitate our antigen engineering efforts by simultaneously allowing the
reactivity of antiserum to be measured against all known antigenic variants of a given protein, and our
humanized mouse-based infection models, which allow us to test the protective efficacy of vaccines during
gonococcal asymptomatic colonization and disease. The results generated by this Core are central to vaccine
design and formulation efforts being undertaken in Projects 1 and 2, and will be used to inform the vaccine
impact modeling being performed in Project 3.